Predicting Short- and Long-term Future Occurrence of Atrial Fibrillation from Single-Lead ECG in Normal Sinus Rhythm with an Explainable Deep Learning Model.

Project Summary/Abstract
More than 30 million individuals worldwide are diagnosed with atrial fibrillation (AF), however, another
13% of individuals with AF are left undiagnosed. People with AF have a five-fold increased risk of stroke
with up to one-third of all strokes shown to be related to AF. Timely administration of appropriate
preventative therapies, especially anticoagulants, can significantly decrease the complications of AF,
including strokes, by 65% and mortality by 30%.
Digital health technologies offer new approaches to identify individuals with undiagnosed AF, in particular
paroxysmal AF (PAF), characterized by occasional episodes of limited duration, for whom a 10-second
12-lead electrocardiography (ECG) performed in the clinical setting is unlikely to overlap with an AF event.
Continuous monitoring is promising, but still costly and burdensome for elderly individuals, who are at
higher risk.
To maximize the diagnostic yield of these technologies, we propose novel methods to predict the future
occurrence of AF from a single-lead ECG during normal sinus rhythm. Only recently it was shown that it
is possible to predict the future occurrence of AF from 12-lead ECGs in normal sinus rhythm collected in
a clinical setting. Here, we propose to predict the occurrence of AF with commercially available single-
lead ECG devices, which will enable a scalable alternative for early detection in a non-clinical setting.
To achieve this goal, we will analyze retrospectively the raw single-lead ECG data of 10,000+ individuals
with PAF over 14 days of monitoring. Validation work will then be carried out in a unique set of 1,718
asymptomatic individuals who participated in the prospective mSToPS clinical trial of AF screening (mean
age 73), with full clinical information and co-morbidities. The three aims of this project are:
1. Compute the probability of a future AF event in the short-term for an individual in normal sinus rhythm
using classic single-lead ECG features and representation learning based features.
2. Develop a method for long-term prediction of AF onset by evaluating individuals with AF detected in
1, 3, 6 and 12 months from the initial monitored period of normal sinus rhythm and by validating the
algorithms using the mSToPS dataset with 3 years of clinical follow-up and annotated co-morbidities.
3. Develop a technique to provide a preliminary interpretation of representation learning features for
time-series data applied to the short- and long-term prediction.
This retrospective study will develop and optimize new predictive techniques from single-lead ECGs,
available through consumer devices, with the goal of identifying individuals at high risk of developing AF.
A future direction to build on from this study's results would include a prospective study of AF prediction
using consumer single-lead ECG to improve clinical outcomes.

Public health relevance
Project Narrative In this project we propose novel methods to predict the future occurrence of AF from single-lead ECGs during normal sinus rhythm, collected from commercially available single-lead ECG devices, which will enable a scalable alternative for early detection in a non-clinical setting. To achieve this goal, we will analyze retrospectively the raw single-lead ECG data of 10,000+ individuals with paroxysmal AF over 14 days of monitoring and we will validate the developed modes using a unique set of 1,718 asymptomatic individuals who participated in the prospective mSToPS clinical trial of AF screening (mean age 73), with full clinical information and co- morbidities. This retrospective study will develop and optimize new predictive techniques from single-lead ECGs, available through consumer devices, with the goal of identifying individuals at high risk of developing AF.